Integrating Machine Learning and Genomic Approaches to Understand Cerebral Small Vessel Disease Pathogenesis from White Matter Hyperintensity Patterns

PROJECT SUMMARY
As a neurointensivist and neurologist at Washington University School of Medicine in St. Louis (WUSM), my
career goal is to develop an independent research program as a computational biologist capable of using
advanced bioinformatics and statistical methods to integrate analysis of large-scale neuroimaging and genetic
data, with the aim of deepening understanding of the biological mechanisms influencing cerebral small vessel
disease (SVD) and identifying new targets for therapeutic development. As a first step towards this goal, I have
designed an innovative proposal that combine machine-learning (ML) methods and integrated imaging genetic
analyses of large-scale neuroimaging and genetic data to improve characterization of SVD disease mechanisms.
The clinical, imaging, and etiologic heterogeneity of SVD have impeded efforts to uncover the
pathophysiology of this common and debilitating neurological disease. White matter hyperintensities (WMH), a
major imaging endpoint of SVD, are comprised of multiple SVD pathologic processes. Growing evidence
suggests location-specific vulnerability of brain parenchyma to different underlying SVD pathologic processes,
in which spatially localized WMH patterns may reflect distinct SVD etiologies. Characterizing WMH spatial
pattern variations in SVD will not only provide insights into underlying pathogenesis, such as vascular amyloid
deposition, arteriolosclerosis, and other less well defined or as-yet unknown disease mechanisms, but also lead
to creation of novel imaging biomarkers of these SVD pathologic processes. This proposal addresses a key
inadequacy, as existing WMH pattern definitions are determined empirically and cannot distinguish overlapping
SVD etiologies and risk factors. In this proposal, I aim to capture WMH spatial pattern variations that reflect
distinct SVD etiologies in an unbiased manner, by applying clustering analysis/ML methods to structural MRI
data to create novel etiology-specific SVD imaging phenotypes. Moreover, given that genetics influence the
variance of WMH, I will integrate genetic analyses of these WMH patterns to uncover novel mechanisms that
influence SVD pathogenesis. My preliminary data demonstrate the feasibility of identifying data-driven WMH
spatial pattern variations, which are specific to distinct SVD etiologies, and allow detection of genetic risk variants
that may help inform SVD pathologic processes.
My career plan leverages the extensive resources and exceptional environments at WUSM, under the
guidance of a multidisciplinary mentorship team with expertise across diverse fields including cerebrovascular
physiology, neuroimaging, informatics, genetics, and machine learning (Drs. Jin-Moo Lee, Daniel Marcus, Carlos
Cruchaga and Yasheng Chen). In this Career Development Award, I propose to: 1) determine distinct WMH
spatial patterns that can discriminate underlying SVD pathology and/or risk factors by applying pattern analysis
ML methods to structural MRI data from three unique cohorts (n=2,710) enriched for different SVD pathologies
(Aim 1a), and examining if the ML-defined WMH patterns segregate individuals by well-defined SVD risk factors
as biologic validation (Aim 1b), and 2) identify genetic variants (Aim 2a) associated with WMH patterns that
reflect diverse pathologic processes influencing SVD using genome wide association and gene-based analyses;
replicate the top variants (Aim 2b) in an independent population-based cohort (n=21,708); and use advanced
bioinformatics tools to uncover new biologic pathways associated with WMH spatial patterns (Aim 2c).
This research proposal and accompanying development plan with focused training in machine learning,
neuroimaging, and multivariate methods for integrated imaging genetics analysis, will build on my background
in genetics towards a career investigating cerebrovascular disorders using translational bioinformatics. This
Award will provide me with the necessary training to evolve into an independent investigator with a computational
research program that can integrate large imaging and genetics datasets to derive results that are highly relevant
to the prevention and treatment of cerebrovascular disease in my clinical patient population.

Public health relevance
PROJECT NARRATIVE Cerebral small vessel disease (SVD) is one of the most prevalent neurological conditions in older adults, and a leading cause of stroke and cognitive impairment, for which existing treatment and preventative options have been limited or lack efficacy. This project’s goal is to enhance our knowledge of the complex disease processes underlying SVD using machine learning and integrating individual imaging and genetic data from over 20,000 adults. By understanding these disease processes, we can design novel methods to more effectively treat and prevent stroke and dementia.